ANCILLARY STUDY OF THE ADOPTION AND SUSTAINABILITY OF ED-INITIATED BUPRENORPHINE (CTN-0079-A-1). DSC5 CONTRACT. 09/20/2019 - 02/28/2021. N01DA-19-2250.

ANCILLARY STUDY OF THE ADOPTION AND SUSTAINABILITY OF ED-INITIATED BUPRENORPHINE (CTN-0079-A-1)